MPI/MRI bimodal imaging for non-invasive tracking of extracellular vesicles targeted to infarcted myocardium

Project summary
Stem cells derived extracellular vesicles (EV) hold great promise for repairing myocardial infarctions (MI), and
there is an urgent need to develop effective EV-based therapies, preferably delivered by systemic administration.
In this context, a robust EV-tracking technology is invaluable to provide the new capability to elucidate the injury
tropism of EVs derived from different cell sources and to guide and further optimize EV-based therapies. The
goal of this Catalyze proposal is to establish a bimodal imaging platform technology for tracking EV delivery to
the injured heart using magnetic resonance imaging (MRI) and magnetic particle imaging (MPI). In our
preliminary studies, we developed a novel labeling strategy for preparing highly purified, magnetically labeled
EVs, dubbed magneto-EVs. Thanks to the magnetic labeling by superparamagnetic iron oxide (SPIO)
nanoparticles, one can use combined MRI and MPI to detect systemically injected EVs in vivo with high sensitivity
and specificity in a high spatial resolution manner. In this Catalyze proposal, we will further optimize and
rigorously validate the MPI/MRI technologies for tracking magneto-EVs beyond the initial prototype
demonstration. In particular, we will 1) optimize magnetic labeling and MPI/MRI acquisition for accurately
detecting magneto-EVs and 2) validate the ability of MPI/MRI to track therapeutic EVs in a mouse MI model.
This line of investigation is significant because it will fill the critical gap in knowledge as to how to track and
improve EV for myocardial repair applications, and this new MPI/MRI has the capability, if optimized, to meet the
unmet need, that is an effective means to investigate the injury-tropism of SC-EVs and thereby promote the
development of more effective, EV-based regenerative medicine for myocardial repair. Furthermore, MRI has
immediate translatability and will facilitate the clinical application of EV therapies in the future, whereas MPI also
has translation potential. The proposed research is innovative because the proposed study will use a novel
labeling strategy, which allows preparing highly purified magneto-EVs efficiently, and an MPI/MRI multimodal
detection approach, which enables quantitative tracking of magneto-EVs in vivo in a high spatial resolution
manner.

Public health relevance
Narrative The project is relevant to public health because we anticipate that our study will significantly advance the development of regenerative strategies using stem cell derived extracellular vesicles to treat myocardial infarctions (MI), the leading cause of death in the United States every year. Upon conclusion, we will have established a translatable imaging platform for monitoring the delivery of stem cell derived EVs to infarcted myocardium that can greatly accelerate the development of more effective EV-based cardiac regenerative medicine and developed an optimized imaging technology that can guide and optimize EV-based therapies, both of which are highly relevant to the part of NIH’s mission.